Evolutionary mechanisms of gastrulation and left-right patterning in amniotes.

PROJECT SUMMARY
Although as humans we appear symmetrical on the outside, our internal organs are asymmetrically positioned
along the left and right sides of our body. Left-right (L-R) patterning is a fundamental biological process that helps
to ensure the correct positioning of our organs, and its perturbation is typically associated with congenital heart
malformations and high mortality. In a typical deuterostome, including humans, proper L-R patterning involves
motile cilia in the L-R organizing (LRO) region, which trigger a Ca2+ wave on the left side of the embryo. This
results in asymmetric gene expression and ultimately asymmetric organogenesis. However, more than 65% of
all tetrapods, including reptiles and even-toed ungulates, do not use motile cilia for L-R patterning. Instead, tilting
of the LRO and asymmetric cellular movements somehow lead to molecular asymmetry. However, the mecha-
nisms underpinning L-R asymmetry in these organisms are poorly understood. It is unclear how asymmetric cell
movements originate, whether they trigger the asymmetrical Ca2+ wave, or if cilia are involved in any aspect of
L-R patterning. Currently, the chicken embryo is used to represent the diversity of all 25,000 species of reptiles,
and new models are required for a deeper evolutionary understanding of fundamental developmental events.
Veiled chameleons (Chamaeleo calyptratus) are perfect for the study of early development and evolution in non-
avian reptiles, since they lay large clutches of eggs at pre-gastrulation stages. Their LRO lacks motile cilia, and
instead molecular asymmetry is established through large-scale morphological changes. Veiled chameleons
have a sequenced and annotated genome, and are amenable to cell and embryo culture, as well as live imaging.
The objective of this application therefore is to define the mechanisms governing L-R patterning in chameleons
and thus expand our understanding of amniote development and evolution. The central hypothesis is that cellular
flow and large-scale morphological changes trigger an evolutionarily conserved asymmetric Ca2+ wave, leading
to molecular L-R asymmetry, which has undergone evolutionary change across amniotes. This hypothesis will
be addressed in the following aims: (Aim 1) Determine the mechanics of establishing L-R patterning in veiled
chameleon. (Aim 2) Evaluate genetic changes and conservation of the L-R patterning pathway across amniotes.
The patterns of cell migration and the dynamics of Ca2+ signaling will be evaluated through live imaging, providing
training in advanced microscopy. CRISPR/Cas9 gene editing will be adapted for use in chameleons and will
include training in surgery and virus production. This study will result in the first scRNA-seq and scATAC-seq
libraries for asymmetric gene expression between the left and right sides of chicken, chameleon, and mouse
embryos, and will involve computational biology training. Successful completion of this project will be significant
in the fields of L-R patterning and evo-devo, providing the first detailed study of the early steps of L-R patterning
in a non-avian, non-mammalian amniote, which may revolutionize our current thinking about roles for cilia and
Ca2+ signaling in L-R patterning. It will also lay the foundation for a successful independent career.

Public health relevance
PROJECT NARRATIVE Proper development of the left and right sides of our bodies is critical for the correct positioning of our organs. Perturbations in this process result in heterotaxy, which is typically associated with congenital heart malformations and high lethality in the first year of life. This study investigates the evolutionary and developmental mechanisms that establish left-right asymmetry, using veiled chameleons as a research organism, and has the potential to discover novel and conserved processes, and advance the diagnostic outcomes for heterotaxy and congenital heart disease patients.